Acquired Resistance to TGFBR1 inhibitors and cancer stem cell outgrowth

DESCRIPTION (provided by applicant): We have recently demonstrated that chronic inhibition of the Transforming Growth Factor-β (TGFβ) signaling pathway by a small molecule TGFβR1 inhibitor in vivo leads to the outgrowth of drug resistant chemically-initiated carcinomas in a mouse skin cancer model. This is the first report of development of acquired drug resistance to a TGFβ inhibitor. Moreover, these drug resistant carcinomas have an aggressive phenotype and show gene enrichment for expression of skin stem cell markers. The goal of the current proposal is to determine whether this molecular profile, indicative of a cancer stem cell, is due to expansion of the functional stem cell compartment, and to elucidate the molecular mechanisms for acquisition of drug resistance. The hypothesis to be tested is that chronic pharmacological suppression of the TGFβ signaling pathway induces a drug-resistant state resulting in constitutively elevated Smad2/3 signaling that supports expansion of the CSC compartment. In Aim 1 we plan to prove this hypothesis using both in vivo and in vitro approaches in the mouse skin model of chemically-induced carcinogenesis. In Aim 2, we will address the molecular mechanisms responsible for acquired drug resistance and CSC outgrowth by mutation screening of archival tissue using ultra-deep sequencing of the exons of target genes, and by undertaking screens for Smad2 activating kinases in vitro. Understanding the molecular mechanisms of acquired drug resistance to TGFβ blocking therapies has the potential to improve treatment strategies and next generation drug design. In addition, because of the intimate association between CSCs and TGFβ signaling, this knowledge has great promise to provide insights into the molecular regulation of CSC maintenance and could provide novel druggable targets for attacking CSCs.

Public health relevance
We have recently demonstrated that cancer cells can acquire resistant to a new anti-TGFβ drug. This resistance appears to support outgrowth of cancer stem cells that are the main villains in maintaining the tumor, allowing tumor spread and causing cancer recurrence after therapy. We intend to find out how the cancer evades this drug at the molecular level, which will provide insight into cancer stem cell biology and provide new targets for attacking cancer stem cells.